Administrative Core

ABSTRACT (ADMINISTRATIVE CORE)
The Administrative Core will leverage resources and provide administrative oversight to ensure smooth
operation of the Indiana Diabetes Research Center (IDRC), including the Research Cores, Pilot and Feasibility
Program, and Enrichment Program. The Administrative Core includes the Director of the IDRC, Dr. C. Evans-
Molina, the Associate Director, Dr. K. Mather, the Executive Administrative Assistant, the Business Manager,
and the Communications Specialist. To support the mission of the IDRC, the Administrative Core will leverage
resources and provide administrative oversight to ensure operation of the Research Cores and the Pilot and
Feasibility Program. In addition, the Administrative Core will create an environment that enriches collaboration
and interaction by providing oversight of the Seminar Series and the Annual Diabetes Symposium. The Co-
Directors assume responsibility for the scientific and educational directions of the Center. The Associate
Director will assist the Directors as needed in the operation of the IDRC. The aims of the Administrative Core
will include:
(1) Encourage membership in the IDRC to ensure the continued growth of the Center's Research Base
of investigators.
(2) Foster the careers of new and promising investigators in the field of diabetes and metabolic
disorders by providing funding, scientific expertise and guidance, and access to technical resources through
the Pilot and Feasibility Program.
(3) Allocate resources (including equipment, personnel, and funds) and oversee charge-back policies
to ensure the financial health of each Research Core and the appropriate flow of reagents and samples
between Cores.
(4) Create an environment that meets the needs of the Research Base and facilitates success through
evolution of the Research Cores.
(5) Minimize redundancy of Core services and charge-backs, and to maximize interaction and
collaboration with investigators from other research disciplines.
(6) Create a stimulating atmosphere that facilitates the training and education of faculty and learners at
all levels through the operation of an Enrichment Program
(7) Inform the Research Base and local community of IDRC activities including seminars, Research
Core services, availability of Pilot and Feasibility funds, and local diabetes-related events through the
maintenance of a dedicated website.